Biostatistics, Epidemiology, and Research Design

The Biostatistics, Epidemiology, and Research Design (BERD) Core has a strong track record of providing assistance with statistical analyses and research design to investigators in West Virginia. In the previous funding cycle, BERD provided over 3000 unique services to over 1200 investigators, in the areas of biostatistics, epidemiology, research design, custom data sets, Geographic Information Systems (GIS), REDCap, and more. In the next funding cycle, BERD will expand the depth and breadth of services available to researchers without compromising the quality or timeliness of their expert assistance. A crucial area of expansion will be the Small Area Estimation Unit (SAEU) (AIM 1). Given West Virginia’s small, rural population, it is imperative to have a group providing statistical expertise for small sample size studies. Additionally, the expertise in GIS will be expanded. A GIS server installed in collaboration with Environmental Systems Research Institute (ESRI) is the first server of its kind to be utilized at an academic institution in North America. This server will allow for more complex and technologically integrated spatial analyses. BERD will be enhancing not only the analytic capabilities of WVCTSI, but also the technical capabilities. The BERD core will be utilizing the newly acquired High-Performance Computing (HPC) cluster and accompanying secure enclave to run resource-intensive big data analyses. This HPC cluster will also support BERD’s expansion in the areas of Artificial Intelligence (AI), Machine Learning (ML),and predictive modeling, enabling development of the next generation of technological tools to impact clinical research and enhance personalized medicine (AIM 2). Finally, as BERD provides cutting-edge methods and technologies, a parallel goal is to increase the knowledge and capabilities of researchers at West Virginia University and all WVCTSI partner institutions (AIM 3). In order to utilize GIS, HPC, and AI/ML offerings to their fullest potential, it is essential to have mechanisms in place for investigators to acquire the necessary skills to effectively use these systems. Therefore, BERD will develop workshops, training courses, and certification opportunities in these areas to facilitate investigator independence and knowledge expansion. Ultimately, over the next funding cycle, the resources of the BERD core will lead to increased productivity and enable new research opportunities.